Bioprinting Patterning for Cell-Laden Constructs

TR&D 2: Bioprinting Patterning for Cell-Laden Constructs Project Summary A major challenge for tissue and organ engineering is the production of three-dimensional (3D) biomimetic, cellular tissue constructs of clinically relevant size, shape, and structural integrity needed for the replacement of damaged or injured tissues. To address this need, we have been investigating 3D bioprinting technologies, which are designed to print cell-laden hydrogel bioinks as well as polymeric biomaterials, to manufacture complex, multi-cellular living tissue constructs that mimic the structure of native tissues. In addition, we have been optimizing the formulation of biomaterials to serve as the scaffolding for 3D bioprinting, and providing the biological environment needed for the successful delivery of cells and biomaterials to specific locations within the 3D structures. It has become evident that the patterning design of the cell-laden biomaterials is critical for achieving adequate nutrition and functional outcomes. In this project, we will (1) develop bioink formulations and functionalize to control cell positioning with high printability, (2) fabricate biofunctional bioink formulations to control the cell microenvironment, and (3) validate bioprinted multiple cell populations with interacting functionalities for bone tissue regeneration in vivo. The results of this project - which will be shared with the broad community - will be to establish the ideal parameters needed for cell positioning during 3D printing of tissues, thus establishing a community wide approach for engineering tissues.

Public health relevance
TR&D 2: Bioprinting Patterning for Cell-Laden Constructs Project Narrative A major challenge for tissue and organ engineering is the production of three-dimensional (3D) tissue constructs of clinically relevant size, shape, and structural integrity needed for the replacement of damaged or injured tissues. We developed a novel 3D bioprinting system that is designed to print living tissue constructs that mimic the structure of native tissues. We aim to develop optimized bioprinting parameters that could recapitulate tissue microenvironment to build multi-cellular living tissue constructs with interacting functionalities. Developing open source formulations for precise cell positioning and functionalized polymer printing would be beneficial for establishing a community wide approach for engineering tissues or organs.